Efficient IBD mapping for Alzheimer's Disease and related brain imaging phenotypes

PROJECT SUMMARY/ABSTRACT
Alzheimer’s Disease (AD) is a highly heritable complex human disease, but only a limited number of its genetic
risk factors have been identified. In this project, we propose to leverage identical-by-descent (IBD) segments,
which are expected to better tag haplotype effects and provide complementary genetic information to additively
coded genotypes that are commonly used in genome-wide association studies, in the genetic association
mapping for AD and related brain imaging endophenotypes. In Aim 1, we will develop the statistical and
computational framework for efficient genetic association mapping using IBD segments in large samples. In Aim
2, we will apply IBD mapping to identify novel genomic regions associated with brain imaging endophenotypes
from the UK Biobank. In Aim 3, we will replicate these associations in the Alzheimer’s Disease Sequencing
Project (ADSP), develop and apply IBD mapping methods to AD, and combine association evidence from diverse
populations in the UK Biobank and ADSP. Our novel tools and findings from this project will be made publicly
available to facilitate novel discoveries that improve our understanding on the genetic architecture of AD and
related brain imaging data.

Public health relevance
PROJECT NARRATIVE Identical-by-descent segments inferred from genome-wide data provide information on population history and genetic relatedness that are not sufficiently used in current genetic association approaches. We propose to leverage identical-by-descent segments in the genetic association mapping for Alzheimer’s Disease and related brain imaging endophenotypes, develop efficient statistical methods and implement novel computational algorithms that can be applied to large samples. Our tools and findings will facilitate genetic research and provide novel insights into the genetic architecture of Alzheimer’s Disease.